Machine and Electronics Shop Core

Objective- The objective of this Core Unit will be to provide machine and electronics shop support for the Project Pi's. All of the projects in this PPG require the use of specially fabricated materials or small electronic devices that will need to be custom manufactured. In many cases these specialized devices will be expected to perform similar functions in different laboratories (e.g. EMG amplifiers, myographs, stimulators) so that fabrication from a central Core Unit is desirable. This Core Unit also will function to repair or modify these items for the Project Pi's.